EnCoRe MOMS: Engaging Communities to Reduce Morbidity from Maternal Sepsis

Maternal sepsis is the second leading cause of maternal death, major cause of morbidity, and preventable in
most cases. Labor, birth, and postpartum are periods of increased sepsis risk, particularly for racial and ethnic
minoritized birthing people. Yet few evidence-based interventions exist. With our extensive community
partnerships and community organized leadership advisory board (CoLAB), EnCoRe
MoMS: Engaging Communities to Reduce Morbidity from Maternal Sepsis will address three highly related
specific aims: (Aim 1) Develop, implement, and evaluate a community-informed maternal sepsis bundle in 4
diverse NYC hospitals; (Aim 2) Develop algorithms to optimize prediction of sepsis around delivery and
postpartum; and (Aim 3) Conduct a co-design process and qualitative study to explore the experiences, needs,
and perceived solutions for maternal care continuity, sepsis prevention, and promotion of equity in postpartum.
In the UG3 phase we will establish robust community engagement and research infrastructures to: Aim 1a:
Design a comprehensive obstetric sepsis bundle that i) applies and optimizes standard evidence-based
components of readiness, recognition, response, reporting, and respectful care ii) incorporates multidisciplinary
obstetric provider implicit bias training, and iii) integrates social determinants of health (SDOH) training and
screening Aim 2a. Create a rich electronic health records (EHR) database from the Perinatal Research
Consortium (PRC). Aim 2b. Collate neighborhood-level datasets characterizing social determinants of health
(SDOH) Aim 3a. (3a.1) Refine our CoLAB and co-design process; (3a.2) Conduct in-depth individual patient
interviews (IDIs) and focus group discussions (FGDs) with community and hospital stakeholders from one site
to explore the lived experiences and perspectives of SDOH on care access/quality, outcome disparities, and
solutions for care continuity. In the UH3 phase, we will engage community to implement our maternal sepsis
care model, analyze results, and translate findings. Aim 1b. Implement our comprehensive obstetric sepsis
bundle and evaluate its effectiveness using process and outcome measures Aim 1c. Define patterns in EHR of
provider response to suspected sepsis, pre- vs post-bundle implementation; analyze associations between
provider response variation and outcomes Aim 2c. Harmonize patient-level EHR and neighborhood-level SDOH
datasets and use machine learning models to analyze the individual and joint contributions of patient and
neighborhood factors to optimize sepsis risk prediction within the PRC sample Aim 3b. (3b.1) Complete
qualitative patient IDIs and stakeholder FGDs for the three additional hospital sites; (3b.2) Co-design an
integrative supportive care model, with our community partner co-lead, CoLAB, and results from other aims, that
entails maternal sepsis community engagement, care linkages, education, services, and policy efforts. Our
resulting model can be scaled to hospitals and communities with lesser resources and applied to other
preventable causes of severe maternal morbidity.

Public health relevance
PROJECT NARRATIVE Sepsis is the second leading cause of maternal death in the U.S. For racial and ethnic minoritized birthing people, especially those who are Black, living in poverty, and from underserved communities, labor and postpartum are particularly vulnerable risk periods. We propose a multicenter, multidisciplinary study, with community co-leadership and co-design, to evaluate a maternal sepsis safety bundle, optimize risk prediction accounting for the social determinants of health, and establish a novel maternal care continuity model to reduce sepsis-related death and disability and increase maternal health equity.